Redox stress resilience in aging skeletal muscle

PROJECT SUMMARY/ABSTRACT
Aging is associated with impaired stress resilience defined as a loss of the ability of cells, organs, and organisms
to adapt to physiological or pathological stressors. Evidence suggests that this loss of resilience arises before
any overt pathology, and eventually contributes to the loss of function, disease, and death. However, the cellular
mechanisms that drive this process are poorly understood. For cells to adapt to environmental and endogenous
stressors they need to be able to communicate the stress signal through signal transduction mechanisms.
However, for transient stress signals to be effective, they should be low under resting conditions. The
transcription factor Nrf2 activates early changes in gene expression to enhance redox and energetic adaptations
in response to acute redox stress associated with muscle contraction. In healthy individuals this leads to an
adaptive response to restore redox balance and increased cellular resilience to future stresses. Nrf2 is
chronically activated under basal conditions and has an attenuated response to muscle contraction in human
aged skeletal muscle. In addition, aging is associated with elevated reversible oxidation of the thiol proteome, a
primary signal transduction mechanism driving redox adaptation, and that reducing mitochondrial redox stress
restores the thiol proteome to that found in young. Here we test the hypothesis that mitochondrial redox stress
in aging muscle is the chronic low-level stress that impairs the signal transduction communication in the cell
underlying the impaired redox stress response to muscle contraction. This research uses skeletal muscle
contraction as a model to generate new insights into the molecular mechanisms underlying reduced resilience
with age. Aim 1 tests whether increasing mitochondrial redox stress is sufficient to drive declining muscle function
and adaptive stress response signaling to acute muscle contraction by characterizing a novel SOD2 Knockdown
mouse model and layering this knockdown to measure redox stress response signaling. Aim 2 tests whether
decreasing mitochondrial or cytoplasmic redox stress is sufficient to restore adaptive stress response signaling
to acute muscle contraction by treating young and old wild type mice as well as mice iSOD2 KD mice with
mitoTEMPO or TEMPO as mitochondrial targeted antioxidant vs a non targeted antioxidant. Results from the
proposed experiments will significantly impact the field by elucidating redox stress response signaling in aging
and age-related muscle/mitochondrial dysfunction. These results will have clear clinical significance as there are
already several mitochondrially targeted pharmacological compounds that are redox active and can be tested in
humans.

Public health relevance
Project Narrative Aging organisms show impaired redox homeostasis and energetic stress. This is associated with declining stress resilience and increased risk for age-associated diseases. We propose to manipulate the chronic mitochondrial redox stress in models of acute muscle contraction in young and aged mice to test whether mitochondrial dysfunction underlies the decreased adaptive stress response with age that drives the decline in muscle function and healthspan.